Clinical Outcome Assessment and Treatment Monitoring Markers for Clinical Trial Readiness in FXTAS

Fragile X-associated Tremor/Ataxia Syndrome (FXTAS) is a rare, inherited, X-linked, late-onset, progressive neurodegenerative disease characterized by intention tremor, cerebellar gait ataxia, parkinsonism, and cognitive decline. Pathologically, it features brain white matter degradation, ubiquitin-positive intranuclear inclusions, widespread astrogliosis, and general atrophy. FXTAS is caused by a trinucleotide (cytosine- guanine-guanine or CGG) expansion between 55 and 200 repetitions within the fragile X messenger ribonucleoprotein 1 (FMR1) gene. Although there are no proven treatments for FXTAS, ongoing studies demonstrate that therapeutic strategies will be available soon in the form of antisense oligonucleotides (ASOs) that target the repeat-containing mRNA, agents that suppress cellular stress cascades, and molecules that lower neuroinflammation and reduce repeat associated non-AUG (RAN) translation. However, without fully validated fit-for-purpose clinical outcome assessments (COAs) and sensitive markers of treatment response, these future pivotal trials may not come to fruition and fail to provide conclusive, clinically meaningful, and impactful results for this devastating and rare disorder. In response to PAR-22-184, “Clinical Trial Readiness for Rare Neurological and Neuromuscular Diseases,” the overall purpose of this Research Cooperative Agreement (U01) application, “Clinical Outcome Assessment and Treatment Monitoring Markers for Clinical Trial Readiness in FXTAS” is to finalize refinement and validation of our primary COA – The FXTAS Rating Scale (FXTAS-RS) and a discrete set of neurocognitive, motor and neuroradiological outcome measures suitable for detection of treatment response. This will be accomplished by the study of 100 men and women with FXTAS who will be assessed at multiple time points over one-year, mimicking procedures that will be used in future clinical trials, including assessments of motor function, cognition, brain structural changes using MRI, and patient reported outcome measures (PROMs). We will document critical properties of the measures such as reliability, validity, sensitivity to change and clinical meaningfulness, and an Advisory Committee including patient self-advocates, clinicians, researchers and drug industry representatives will guide the work. We will develop a training program for clinical trial site teams to use the FXTAS-RS and harmonization of other measures will occur across the sites. By the end of this 5-year project, we will have 1) a validated fit-for- purpose primary COA and a discrete set of key cognitive and motor secondary endpoints for FXTAS clinical trials; 2) neuroradiological markers that are sensitive to FXTAS disease state and progression; and 3) a rigorous multi-center harmonized protocol and infrastructure that is ready to conduct Phase 2/3 trials for FXTAS.

Public health relevance
Fragile X-associated Tremor/Ataxia Syndrome (FXTAS) is a rare, inherited, X-linked, late-onset, progressive neurodegenerative disease with no specific treatments currently available. The purpose of this Clinical Trial Readiness project is to establish a set of valid, reliable and sensitive clinical outcome measures, to include electronic measurement of tremor and balance, and brain imaging markers that will be used in future clinical trials of patients with FXTAS to monitor treatment response. These measures will be optimized across multiple clinic sites and guided by an Advisory Committee comprised of patient advocates, clinicians, researchers, and drug industry representatives.